Identification and targeting of metabolic profiles in cytotoxic T-lymphocyte (CTL)-resistant, HIV-infected CD4+ T-cells

PROJECT SUMMARY/ABSTRACT
HIV infection remains an unmet global health and socioeconomic burden lacking a safe and scalable cure or a
vaccine for prevention. While in the last decades the development of highly effective antiretroviral therapy (ART)
has revolutionized infection outcome drastically decreasing transmission and AIDS-related mortality/morbidity
among infected individuals, treatment remains a lifelong burden. This is due to the inability of ART and the
immune system to clear rare intact, transcriptionally competent and persistent proviruses already integrated into
the genome of infected cells – the HIV reservoir. Viral latency is a crucial barrier towards eliminating the HIV
reservoir, enabling viral immune escape through transcriptional silence during ART. However, recent lines of
evidence have demonstrated that low level HIV production persists over years of ART and correlates with HIV-
specific cytotoxic T-lymphocyte (CTL) responses that shape the HIV reservoir. This suggests that rare cells with
transcriptionally active proviruses are actively surveilled by HIV-specific CTL responses but are unable to be
eliminated. Profiling of the HIV reservoir has also demonstrated that persistent HIV-harboring cells become
preferentially clonal and express molecules that can inhibit CTL cytolytic interactions with infected target cells
(BCL-2, SERPINB9 and PVR), further implicating CTL resistance as a mechanism of infected cell persistence.
Our preliminary work using an in vitro infection model designed to evaluate CTL resistance in infected cells has
demonstrated that a rare subset of HIV-expressing cells is preferentially resistant to CTL elimination. Multiomic
analysis of these rare cells has confirmed the presence of previously suggested features of CTL resistance, and
further revealed a vastly shared transcriptional and surface protein signature denoting dampened levels of
metabolic flux and oxidative stress. Here, we aim to demonstrate the presence of a metabolic profile skewed
towards quiescence in CTL resistant, HIV expressing infected cells. We hypothesize that lower levels of
metabolic flux puts CTL resistant infected cells at a lower threshold of oxidative stress than the general population
of infected cells, making them harder targets to push over the edge of irreversible and lethal damage. The
experiments of this proposal will evaluate the therapeutic value of pharmacologically inducing oxidative stress in
HIV-infected cells to improve CTL mediated elimination of infected cells and HIV reservoirs.

Public health relevance
Project Narrative: HIV infection remains a major health burden with approximately 40 million people affected globally. Antiretroviral therapy can suppress viral replication and transmission but it is required as a lifelong treatment to prevent viral rebound from an established subset of infected cells making up the HIV reservoir. This project aims to understand how HIV reservoir cells making HIV antigens are shaped by their intrinsic metabolic status to survive cytotoxic T-lymphocyte (CTL) recognition, and identify pharmacologic perturbations to sensitize these cells for improved CTL-mediated elimination in an effort to advance immunotherapies to eliminate HIV reservoirs.